University of California Global Health Institute Program for Fellows and Scholars

Project Summary In response to RFA-TW-16-002, the University of California Global Health Institute (UCGHI), including UC San Francisco (UCSF), UC San Diego (UCSD), UC Los Angeles (UCLA) and UC Davis (UCD), along with a network of 20 collaborating international institutions proposes to continue their successful UCGHI GloCal Health Fellowship (GloCal). Our international sites are well-established, work in regions with some of the highest burden of disease, and stand to benefit from our program's capacity building, mentorship training and alumni support. GloCal is the only UC-wide global health training program, and our track record shows that we: 1) Recruit pre- and postdoctoral trainees diverse in discipline and ethnicity who aspire to build interdisciplinary academic research careers in global health; 2) Provide outstanding, interdisciplinary education and training in global health in collaboration with over 160 faculty mentors from participating UC campuses and 20 collaborating international institutions; and 3) Provide each trainee with a rich and enduring mentored research experience that fosters scientific and career development in global health. The program also advances long- term objectives to: 1) Develop models of interdisciplinary, innovative global health research and training designed to improve health for populations around the world; 2) Broaden and expand the global health faculty across the four UC campuses and international partner institutions; and 3) Strengthen global health networks. GloCal recruits candidates from a pipeline of 46 T32 and 14 D43 programs, supported by 12 of the 20 NIH Institutes. GloCal trainees are at different career stages, but all receive: 1) A 12-month, hands-on research experience on-site with one of our international partners; 2) A strong, interdisciplinary mentored research experience; 3) Instruction in global health and related topics through on-site and online courses; and 4) Career development to ensure that they attain their short-term goals and succeed in transitioning to the next career stage. GloCal leadership and standing committees ensure that these four program components form a seamless, integrated experience supported by evaluation and continuous improvement. Innovations of the program include: 1) A unified consortium under UCGHI that includes four UCs at the leading edge of global health 2) Recruitment of diverse trainees across UC and the UCLA Charles Drew University partnership; 3) Faculty that regularly interact and collaborate on interdisciplinary research; 4) Mentors offering training in diverse disciplines (e.g., medicine, nursing, pharmacy, dentistry, public health, veterinary science, agriculture, environmental and social sciences); 5) Training experiences on a wide range of significant global health issues including HIV, women's health, noncommunicable diseases, mental health, neurological disease, and planetary health; 6) Leveraging common resources across the four participating UC campuses (UCGHI, CTSAs and CFARs); and 7) A mentor training program that helps to build a culture of mentorship at international partner sites. UCGHI is committed to supporting the success of GloCal, as evidenced by their pledge of $600,000 in co-funding.

Public health relevance
Project Narrative The fellows and mentors trained by this program will contribute to short- and long-term improvements in global health prevention and treatment. Their research will help develop clear and effective programs and policies to advance global public health, including care for HIV/AIDS, emerging infectious diseases, noncommunicable diseases, mental health, women's health and planetary health.